Investigation of the Carcinogenic Effects of Bactericidal Antibiotics in the Gut

Project Summary/Abstract
Colitis-associated cancer (CAC) refers to the pathological transition from inflammatory bowel disease (IBD) to
colorectal cancer (CRC). Burgeoning evidence suggests that the abnormal intercellular crosstalk between the
gut microbiome and inflammatory host cells is highly associated with the development of CAC. Thus, mapping
the microbial signature and epithelial plasticity in response to the host-microbiome intercellular crosstalk is critical
to mechanistically decipher the role of gut microbiome on the CAC pathogenicity. However, current animal
models neither reflect the heterogeneous genetic variants in CAC patients nor quantitatively visualize host-
microbiome molecular crosstalk in a spatiotemporal manner. In vitro co-culture models lack the long-term stability
to perform a longitudinal host-microbiome study that is necessary to investigate the pathological intercellular
crosstalk. Hence, developing a patient-specific CAC model that can quantitatively assess the cellular and
molecular signature of host-microbiome crosstalk is a critical unmet need to map the pathological host-gut
microbiome crosstalk and unravel their cause vs. consequence in CAC. The long-term goal of the outlined
research is to develop transformative and implementable engineered cancer model systems that encompass
cancer-microbiome crosstalk. In the F99 phase of this proposed research, a patient-specific CAC-on-a-chip
model will be developed by utilizing a cutting-edge human organ-on-a-chip technology. The effects of gut
microbiome in the development of CAC will be investigated using this model system. In the K00 phase, single-
cell analysis and multi-omics approach will be incorporated into the personalized CAC model for a higher
resolution and comprehensive study of the underlying molecular and cellular mechanism of the defined host-
microbiome intercellular interactions. By mapping crosstalk between cancer and microbiome, complicated
cancer pathobiology will be dissected and manipulated to answer the pressing questions.

Public health relevance
Project Narrative The role of the gut microbiome in colitis-associated cancer (CAC) has been poorly understood because a patient- specific experimental model that can reflect heterogeneity and host-microbiome dynamics do not exist. My research proposes to develop a patient-specific CAC Chip by integrating a microfluidic human gut-on-a-chip and patient-derived intestinal organoids to demonstrate complex host-gut microbiome crosstalk. The ultimate goal is to map the cancer-microbiome crosstalk pertinent to the CAC by leveraging the single-cell multi-omics analysis, which may produce a broader impact on developing new target-specific anti-cancer drugs and uncovering the underlying disease mechanism.